Emerging Diffuse Optical Imaging Technologies for Precision Medicine

TR&D4: Emerging Diffuse Optical Technologies for Precision Medicine
Project PI: Arjun Yodh, PhD
Abstract
This proposal aims to develop and utilize diffuse optical technologies for precision medicine. Diffuse optics is a
field of biomedical optics that uses near-infrared (NIR) light to non-invasively probe living tissues located
millimeters to centimeters below tissue surfaces (deep tissues). NIR light is strongly scattered in tissue but is
weakly absorbed; thus, it can penetrate long distances in tissue. Under these conditions, light transport is well
approximated as a diffusive process. Using this diffusion model, it is possible to quantitatively separate tissue
scattering from tissue absorption and thus to carry out optical spectroscopy of deep tissues. Analysis of these
optical spectra, in turn, permits determination of the concentration of tissue chromophores. Use of the diffusion
equation also enables tomographic image reconstruction of tissue optical and physiological properties. The
proposed work uses two types of Diffuse Optical Spectroscopy (DOS), frequency-domain (FD-DOS) and
broadband (bDOS) diffuse optical spectroscopy, to measure tissue absorption and scattering, which in turn
permits quantitative determination of the tissue concentrations of important physiological parameters such as
oxy- and deoxy-hemoglobin, lipid and water, and both oxidized and reduced forms of cytochrome-c-oxidase. The
proposed work also utilizes a qualitatively different optical technique called Diffuse Correlation Spectroscopy
(DCS), which probes temporal fluctuations of light scattered in tissue that are sensitive to blood flow. The
combination of oxygen saturation and blood flow information from FD-DOS/DCS can be used to derive
quantitative information about tissue oxygen metabolism (CMRO2) based on hemodynamics. The combination
of bDOS/FD-DOS and bDOS-alone can be used to derive metrics of mitochondrial (cellular) metabolism. These
complementary metrics of tissue metabolism provide a new window into tissue health.
The proposed projects will provide unique benefits in clinical research applications. The technology is portable,
compatible with a wide range of measurement environments, and offers unique diagnostic capabilities for
dynamic physiological monitoring. These capabilities, and the comparatively low cost of optical devices,
complement the MRI methods under development in the center. Each aim of TRD4 addresses technological
needs with potential to facilitate individualized treatment for patients, i.e., precision medicine. Aim 1 focuses on
real-time bedside measurements of cerebral blood flow in regions of the brain covered by hair; it has immediate
applications in intensive care studies of brain-injured patients and for real time monitoring of neuromodulation
therapies. Aim 2 develops broadband spectroscopic instrumentation and combines it with FD-DOS to measure
cytochrome-c-oxidase (CCO) concentration in both its oxidized and reduced forms; CCO is a molecular
biomarker for mitochondrial function. Concurrent CCO and hemodynamics measurements should elucidate
mechanisms of tissue injury, e.g., oxygen delivery versus mitochondrial malfunction, and could provide early
warnings about brain health following CPR. Aim 3 develops, adapts, and applies traditional and emerging data
science analysis strategies to enhance the value of diffuse optics tools (from Aims 1,2) for brain injury diagnosis
and management; the tools will also have value for diagnosis of cancer in our Service Projects. Each application
holds promise for individualizing patient care (precision medicine).